Task A28: In Vitro Screening for Antibacterial Activity Against Disease Pathogens

This contract provides in vitro testing of potential anti-bacterial agents, efficacy to combat the effects of toxins produced by bacteria, maintenance of bacterial and toxin stocks, and the development of related assays.